Drug markets and the opioid epidemic

Project Summary: The United States substance use epidemic is one of the most significant health crises in
history, having claimed the lives of more than 1 million Americans since 1999. Despite a significant literature
on the epidemic, there is still much we do not know. This project will address two open questions. The first is to
study the effects of enforcement interventions in prescription drug markets. Under the Controlled Substances
Act (CSA), physicians, pharmacies, and pharmaceutical distributors who handle controlled substances have
obligations to prevent diversion (i.e., illicit uses of controlled substances). In the case of opioids, a number of
physicians, pharmacies, and pharmaceutical distributors were shut down or faced criminal charges due to
violating their CSA obligations. The effects of these interventions on opioid supply and health are unknown.
The proposed project will assemble new data on all federal enforcement interventions related to prescription
opioids since the mid-2000s. These data will be supplemented with individual practitioner and firm-level data
on opioid supply and used to construct a measure of exposure to enforcement interventions for all U.S.
counties over time. Aim 1 will use time-series analysis to estimate the impact of enforcement interventions on
county opioid supply. To study health, the project will use restricted-use vital statistics data from the National
Center for Health Statistics (NCHS) to measure county overdose death rates. Aim 2 will use this data, along
with the enforcement data and same methodology as aim 1, to estimate the impact of enforcement
interventions on deaths from prescription opioids, illicit opioids, and all drugs.
The second question this project will examine is what economic and social factors can explain
continuously rising deaths from illicit opioids (i.e., heroin and illicitly manufactured fentanyl). Illicit opioid deaths
have risen essentially continuously for ten years after policy began reducing prescription opioid supply. Aim 3
will examine two economic and social theories about why. The first theory is downward sloping illicit drug
supply. This theory is that greater opioid use generated economies of scale in drug trafficking, and that this has
reduced illicit opioid prices and increased use. The second theory is about thick markets. This theory is that
greater illicit opioid use has increased people’s social interactions with illicit opioid users and sellers, and that
these interactions have further increased illegal opioid use. The project will draw from the NCHS vital statistics
data, along with a number of other datasets, to test how much each theory can explain rising illegal opioid
deaths. Time-series regressions will be estimated at the county-level during the expansion of the opioid
epidemic from prescription opioids to heroin (2006 to 2014) and from heroin to fentanyl (2010+). To test the
thick markets theory, regressions will relate exogeneous increases in illicit opioid use in nearby areas and in
areas counties have high numbers of Facebook friends with on county’s own illegal opioid death rates. To test
downward sloping supply, regressions will relate exogeneous increases in heroin use to heroin prices.

Public health relevance
Project narrative: Drug overdose death rates have increased essentially every year since 1990. We do not adequately understand how to intervene and reduce drug deaths or what measures we should take to prevent future drug epidemics. This project studies the impact of enforcement interventions in prescription opioid markets on local opioid supply and health outcomes and explores what economic and social factors can explain rising deaths from illicit opioids.